Virginia Pregnancy Risk Assessment Monitoring System

DESCRIPTION (provided by applicant): Modified Project Summary/Abstract Section The Pregnancy Risk Assessment Monitoring System (PRAMS) is a surveillance project conducted in cooperation with the Virginia Department of Health (VDH) and the Centers for Disease Control and Prevention (CDC). Virginia will collect, analyze and disseminate population-based data on maternal attitudes and experiences to provide state health officials with data to use to improve the health of Virginia's mothers and infants.

Public health relevance
Modified Public Health Relevance Section This surveillance of new mothers in Virginia will provide information needed to assess state policies and programs designed to improve maternal, infant and child health in the Commonwealth.